Real time scattered x-ray imaging for tumor motion tracking in radiotherapy.

PROJECT SUMMARY
Stereotactic Body Radiotherapy (SBRT) has been established as an effective, safe, and feasible first-line
option in lung cancer. The quest for dose escalation to increase tumor control and survival benefit, and
simultaneously to minimize normal tissue complication, requires precise radiation delivery to a region including
the cancerous target and the smallest possible ring region around the target (called margin) to ensure sufficient
dose to the target in the presence of positioning uncertainty, mainly caused by respiratory motion. This is
especially critical for SBRT, as it is vulnerable to geometry errors due to high dose per fraction, a steep dose
gradient, and the long delivery time that increases chances of changes in motion. Pre-treatment imaging
technologies have been used to aid the position of tumor against the treatment beam. Yet, a margin size of 6-
10 mm is still routinely used to accommodate systematic and random changes in respiratory motion
magnitude, baseline, and period. Consequently, high dose (close to prescription level) is delivered to a large
volume of normal tissue, yielding toxicity concern. There is a strong, but unmet need for margin reduction in
lung SBRT. The ultimate form of margin reduction is 4D radiotherapy (RT) that modifies multi-leaf collimator
positions in real time in response to tumor motion to always direct radiation to the tumor. Knowing tumor
position in real time is the prerequisite for 4D RT. Nonetheless, to date, no approach can provide accurate and
reliable 3D tumor tracking. To address this problem, our group proposed in 2016 a tumor tracking scheme by
measuring scattered x-ray photons and lately demonstrated its potential feasibility using state-of-the-art photon
counting detection technology. The overall goal of this proposal is to develop and translate a prototype system
with appropriate capability for 3D tumor tracking, to evaluate its performance in phantom and patient studies,
and to demonstrate its clinical impacts, by jointing the strong and complementary expertise of teams at Johns
Hopkins University, Massachusetts General Hospital, and Varex Imaging. We will pursue four specific aims
(SAs). SA1. Develop a prototype hardware system to image tumor region with scattered kV photons. SA2.
Develop a software system for data processing pipeline and tumor tracking. SA3. Integrate the developed
systems to form a prototype and perform phantom experiments to characterize its performance. SA4.
Implement the system in clinic, perform patient studies to demonstrate feasibility and advantages of real-time
3D tumor tracking, and translate it to end users. The innovation of this project is a novel system measuring
scattered kV x-ray photons to image tumor regions and using it to track tumor motion. Deliverability is ensured
by preliminary studies and the team with complementary expertise. Our project will overcome a major hurdle in
4D RT, enabling margin reduction in lung cancer SBRT and hence generate substantial clinical impacts.
Although focusing on lung cancer SBRT, the technology is expected to be translatable to many other tumor
sites facing the same need for real-time tumor tracking.

Public health relevance
NARRATIVE This proposal will develop and translate a novel imaging method called Kilo-voltage Real-time Imaging using Scattered Photons (KRISP) for real-time 3D lung tumor motion tracking and demonstrate its feasibility and advantages in lung cancer radiation therapy. The proposed study will have a high clinical impact, as it will overcome a major hurdle in 4D radiation therapy, enabling this novel therapeutic approach to reduce margins and therefore normal tissue complications in lung cancer radiotherapy, while maintaining tumor control.